New Immune Responses After Papillomavirus Vaccination

The purpose of this IAA is for the CDC HPV Laboratory to conduct the analysis of the antibody response to HPV vaccination in samples that were collected from a NIAID study that looks at the varying immune responses to adolescents receiving the HPV vaccine on schedule and with altered immunization intervals.